The Impacts of Enhanced Drug-Patent Examination

OTHER PROJECT INFORMATION – Project Summary/Abstract
THE IMPACTS OF ENHANCED DRUG-PATENT EXAMINATION
The legal patentability requirements are designed to respect the balance between patient access to existing
longevity-improving drugs and incentivizing their existence in the first place. However, the patent system may
fail to achieve this balance if it does not provide patent examiners with the resources—mainly, time—needed to
apply these patentability standards. Given the legal presumption of validity of incoming patent applications,
insufficient examination time may lead to concerns that the U.S. Patent and Trademark Office (PTO) will issue
patents on non-novel or obvious innovations, a result which may unnecessarily inhibit patient access and
thereby compromise patient outcomes. Patent quality concerns of this nature have been particularly
paramount in the case of “secondary” patents—i.e., patents on subsidiary drug features such as on routes of
administration. Given that secondary patent applications are often filed years after the issuance of the active-
ingredient patent, they have the potential to meaningfully extend the effective patent lives of given drug
products, potentially limiting access on the margin to clinically valuable drugs. In this project, we propose to
investigate the full extent to which secondary patenting practices may be extending effective patent lives of
FDA-approved drugs. Further, drawing on certain PTO reforms and features, we will investigate the impacts of
increasing examination time on drug-patent examination quality. In particular, we will address four aims:
 Compiling, reviewing and coding data from both the PTO and the FDA, we will build a database of
small-molecule drug patents associated with FDA-approved drug products from the mid-1980s to the
present, containing various information associated with each such patent, including information (if any)
on claims associated with secondary drug features.
 We will similarly build a database of large-molecule drug patents, though this effort will likely require a
deeper and more extensive review of raw PTO materials given the lack of a congressionally mandated
list of biologics-related patents associated with FDA-approvals.
 Using these data and employing various quasi-experimental approaches, we will estimate the
relationship between the examination time allotted to examiners and the likelihood that the patents they
issue meet the legal patentability requirements.
 Drawing on the results from Aim #3, we will run simulation exercises to assess the degree to which an
increase in examination time will shorten the effective patent lives of approved FDA drug products and
thereafter draw on various estimated moments from the generic-entry literature to estimate the resulting
effects on increased/accelerated patient access to approved medications.

Public health relevance
OTHER PROJECT INFORMATION – Project Narrative Invalid drug patents, particularly invalid patents on secondary drug features (e.g., routes of administration) have the potential to prolong effective patent lives and delay widespread patient access to longevity-improving drugs. This project will explore the effects of increasing the resources to U.S. patent examiners—mainly, the time allocated to patent examiners—on the rate of issuance of invalid drug patents, while also exploring the efficiency of screening valid from invalid drug patents at the administrative-agency level relative to doing so via the courts. In the process, this project will construct novel databases on both small- and large-molecule drug patents that will prove valuable both to our investigation into strengthening ex ante review of drug patents and to the broader community researching drug patents.